Targeting the PD-1H (VISTA) Pathway to Overcome Immunosuppression in Acute Myeloid Leukemia

SUMMARY
Acute Myeloid Leukemia (AML), driven by rapid myeloid cell proliferation, presents a significant challenge due
to its high mortality and limited treatment options. Despite advances in AML biology, chemotherapy remains the
primary treatment, often failing to prevent relapse. Immune checkpoint blockade (ICB) therapies, effective in
solid tumors, show limited efficacy in AML, likely due to distinct immune pathways in its tumor microenvironment
(TME). This underscores the need for therapies targeting AML’s unique immunosuppressive environment. PD-
1H (Programmed Death-1 Homolog, also known as VISTA) has emerged as a promising immunotherapeutic
target. Our recent studies reveal that PD-1H is highly expressed in the AML microenvironment, and mouse
models show that PD-1H promotes immune suppression and accelerates AML progression, underscoring its
therapeutic potential. These findings set the stage for determining the mechanisms by which PD-1H regulates
immune suppression in AML and its potential as a therapeutic target.
Aim 1 seeks to elucidate the cellular and molecular mechanisms by which PD-1H mediates immune
suppression in AML. We hypothesize that (1) PD-1H shifts myeloid cell populations from pro-inflammatory to
anti-inflammatory states, and (2) uses its unique structural domains to interact with LRIG1 on T cells, leading to
direct T cell suppression. To test this, we will use myeloid lineage-specific PD-1H knockout mice, combined with
single-cell profiling and functional assays, to analyze how PD-1H regulates different myeloid lineages within the
AML microenvironment. We will then use PD-1H structural mutants to identify critical functional domains
underlying immune suppression. To examine LRIG1’s role as a receptor, we will employ LRIG1 knockout T cells
and T cell-specific LRIG1 knockout mice to determine its role in T cell inhibition and AML progression. Aim 2
focuses on developing novel immunotherapeutic strategies by targeting the PD-1H pathway in AML. We
hypothesize that PD-1H inhibition will enhance anti-AML immunity. To thoroughly assess the role of PD-1H in
human AML, we will analyze longitudinal bone marrow samples from AML patients at various stages to track the
expression dynamics of PD-1H and other immune checkpoint markers. We will test new monoclonal antibodies
that fully block PD-1H/LRIG1 interaction, evaluating their efficacy in primary mouse AML models and humanized
AML models with patient-derived xenografts. We will also test a novel combination of anti-PD-1H with anti-TIM3
in AML. This approach integrates patient-derived data with in vivo efficacy testing to support the translational
potential of PD-1H-targeted therapies, laying the groundwork for clinical applications.
This project combines mechanistic studies with innovative therapeutic approaches, aiming to establish PD-
1H as a central target in AML. By addressing AML's immune-suppressive TME through PD-1H, we hope to
advance immunotherapeutic strategies that could significantly improve patient outcomes.

Public health relevance
NARRATIVE This research aims to enhance Acute Myeloid Leukemia (AML) treatment by focusing on PD-1H, a pivotal immune checkpoint that plays a key role in AML's distinctively suppressive microenvironment. Employing a comprehensive strategy, we aim to elucidate cellular and molecular mechanisms of PD-1H mediated immune suppression, particularly in interaction with its novel receptor, and the development of immunotherapies by blocking this pathway. This comprehensive approach is strategically crafted to bridge the gap in our understanding of the uniquely suppressive microenvironment in AML, with the goal of significantly improving patient outcomes in AML treatment.